Small Molecule Therapeutic Discovery for Angelman Syndrome

PROJECT SUMMARY
Angelman syndrome is a severe neurodevelopmental disorder caused by maternal allele deletions of UBE3A.
In neurons, the paternal allele of UBE3A is epigenetically silenced. Unsilencing the paternal allele of UBE3A
offers a potentially transformative opportunity for treating Angelman syndrome. We recently discovered a small
molecule that unsilences the paternal allele of UBE3A in neurons cultured from Angelman syndrome model
mice or from stem cells derived from Angelman syndrome individuals. When delivered noninvasively to
Angelman syndrome model mice, this small molecule leads to brain-wide neuronal UBE3A protein expression
without observable toxicity. We hypothesize that our small molecule approach can reverse Angelman
syndrome phenotypes in mice, justifying its advance towards additional safety studies and future clinical trials.
Towards developing this approach as a non-invasive treatment for Angelman syndrome, we propose to (1)
establish rescue of behavioral and electrophysiological phenotypes in Angelman syndrome model mice, (2)
identify the mechanism of action by which our small molecule produces unsilencing of paternal UBE3A, and (3)
perform structure-activity-relationship studies to improve efficacy and maximize favorable pharmacology. By
advancing the first small molecule treatment of Angelman syndrome, this research may lead to therapy yielding
profound lifelong benefits for this patient population.

Public health relevance
PROJECT NARRATIVE No effective treatment exists for Angelman syndrome, a neurodevelopmental disorder caused by maternal allele deletions of the UBE3A gene. However, activation of the epigenetically-silenced paternal UBE3A allele in neurons offers an attractive therapeutic target. We have discovered a small molecule that can be administered peripherally to unsilence the dormant paternal UBE3A allele throughout the brain, and we propose to advance this small molecule towards a potentially transformative treatment for Angelman syndrome.